Correlative Science

Abstract
Core C will provide biobanking, data and metadata analysis pipelines, and novel correlative assays for each of
the proposed projects. The planned Core C aims are a natural extension of previous biobanking and correlative
assay development and implementation activities in the Stanford Division of Blood and Marrow Transplantation
and Cellular Therapy (BMT-CT). The BMT-CT Biobank currently manages the collection, storage, and
distribution of tissue specimens for translational research on IRB-approved tissue repository protocols. Since the
Biobank’s inception, tissue samples have been collected longitudinally from patients undergoing hematopoietic
cell transplantation, as well as all related and unrelated allogeneic donors. Recently, BMT-CT biobanking efforts
were expanded to include patients treated on investigator-initiated chimeric antigen receptor T cell (CAR T) trials,
as well as standard-of-care and selected industry-sponsored CAR T cell therapy trials. Over 100,000 plasma
and 85,000 PBMC samples are currently stored in the BMT-CT Biobank, and the continuation of these successful
biobanking efforts will provide an essential resource for ongoing and future correlative research. BMT-CT
investigators also have a proven history of developing and implementing human correlative PK/PD assays in the
transplantation and cell therapy space. We have recently utilized single cell RNA sequencing (scRNA-Seq)
approaches for characterization of CAR T cell biology ex vivo as well as CAR T cell efficacy, durability, and
safety in vivo. However, the application of this and other multiparametric, data-intensive techniques is limited by
highly complex data analysis requirements. We have created a large, multi-cloud clinical trial data platform that
orchestrates the ingestion and harmonization of patient data from over a dozen sources and stakeholders –
ranging from patient clinical attributes obtained from the hospital EMR system to molecular assays like qPCR
and scRNA-Seq. We are now proposing to continue the development of this automated pipeline to increase the
efficiency of data analysis and transform the application of single cell sequencing and other multiparametric
approaches in the academic setting. Finally, we are collaborating with Stanford Pathology using our dedicated
multiplexed single cell imaging platform. This method allows simultaneous evaluation of 30-100 antigens from
the planar surface of a single tissue slide and enables deep profiling of complex lymphoma and other tumor
samples with complicated combinations of antigen expression. We intend to utilize this imaging and spatial
analysis platform for Stanford BMT-CT translational research projects and will prioritize projects identified in this
program project. In summary, this Core will continue to support and enhance the established biobanking
operations, data analysis infrastructure, and correlative analyses provided by the BMT-CT Division. The
proposed Core C activities will enable project investigators to scientifically monitor transplantation and cellular
therapy clinical trials and will ultimately advance our understanding of the correlatives of clinical response in
these important studies.

Public health relevance
Core C Project Narrative The BMT-CT Biobanking, Bioinformatics Pipeline, and Spatial Imaging Core (Core C) uses state-of-the-art facilities, service centers, and technologies to support investigators of the Program Project Grant by providing dedicated support for biobanking, data analysis, and spatial imaging in a highly integrated and directed way. Centralized performance of biobanking, bioinformatics infrastructure, and correlative research activities will avoid duplication of effort in the program and ensure timely, efficient, comparable, and consistently high-quality results.